Innovative Tools for Chemical Synthesis: Metal-Hydride Catalysis, Medicinal Motifs, and Molecular Probes

Project Summary
Research and training in organic synthesis impacts all fields of science that require the design and construction
of molecular architecture. This project will advance catalytic methods, including hydroacylation and
hydroamination, as attractive and powerful tools for chemical synthesis. The coupling methods proposed are
modern and innovative because they rely on common functional groups (e.g., aldehydes, amines) to generate
new carbon-carbon and carbon-nitrogen bonds from unsaturated partners (e.g., styrenes, dienes,
cyclopropenes), with high selectivity and atom economy. Through experimental and theoretical studies, this
project will yield fundamental insights into the mechanism of various transition metal catalysts, including rhodium,
cobalt, and copper. Beyond catalysis and mechanistic studies, we plan to build chemical motifs of high
significance to the field of drug discovery. We target privileged motifs (e.g., chiral nitrogen-containing
heterocycles) and explore chemical space (e.g., tricyclic cages bearing high sp3 character). Through
partnerships with experts in other fields, we address exciting challenges in fluorescent microscopy, NMR
spectroscopy, and cancer immunotherapy by designing functional molecules. This project demonstrates
innovation in making molecules at the interface of catalysis, medicinal chemistry, and biology.

Public health relevance
Project Narrative This project will enhance our capability to invent therapeutics and subsequently prepare these medicines on large-scale. Inspired by Nature’s catalyst, we develop ideal, environmentally friendly, and powerful ways to transform simple building blocks (aldehydes, alkenes, and alkynes) into architectures relevant to medicine. Our expertise in molecular design and synthesis will also be applied to address challenges at the interface of chemical theory, fluorescent microscopy, and drug discovery.